A Public Health Foundation for Translating Genomics and Precision Health Applications into Cancer Control and Prevention

The purpose of this agreement is to advance the effective translation of cancer genomics and precision health applications into clinical and public health programs that can reduce the burden of cancer in the United States. Under the terms of this agreement, OGPPPH will collaborate with DCCPS and the CDC Division of Cancer Prevention and Control to: 1) identify and disseminate information, tools and resources about emerging cancer genomic and precision health applications using weekly horizon scanning functions and online knowledge base; 2) develop partnership and collaborations to integrate evidence-based cancer genomics into healthcare and public health programs; 3) sponsor public health surveillance, applied research pilot projects at CDC and state cancer programs; 4) conduct evidence evaluations and health impact analyses for best practices and ways of implementation; 5) provide training and consultation to public health departments and health care providers; 7) develop communication products to public health and healthcare providers and to the general public.